Early Home Influences on Math Learning in Young Children from Diverse Families

PROJECT SUMMARY
Mathematics are essential skills for daily living as well as academic success and future employment. Yet in the
U.S., economic, racial, and ethnic disparities exist in children’s math skills from school entry through K-12
education. One possible contributor to differences at the start of kindergarten could be differential verbal
inputs about mathematics by parents – also known as “math talk.” Research, almost exclusively with mothers
and in English, finds that math talk in early childhood contributes to math skills in preschool and kindergarten.
However, little is known about math talk by fathers, math talk in Spanish or bilingual English-Spanish parent-
child interactions, or combined caregiver math talk and their effect on math skill development. Capitalizing on
the NICHD-funded Baby Books 2 project, a bilingual (English-Spanish) longitudinal parenting intervention for
low-income, ethnically/racially diverse, first-time parents and their young child, we explore the prevalence and
diversity of math talk in recorded mother-child and father-child play and reading interactions at 9, 18, 24 and
30 months. We compare, through observational coding and textual analysis of transcripts, the frequency,
variety, and types of math talk that parents engage in with their very young children, in English and Spanish.
We also assess how mothers’ and fathers’ math talk, independently and together, contribute to children’s math
skills assessed at 38-46 months, after controlling for parental (e.g., nativity, education, mental health) and
child (e.g., temperament, language skills) characteristics. This research will increase our understanding of early
parental contributions to young children’s early math skills and, potentially identify the types of verbal inputs
that are most supportive for low-income, minoritized children’s school readiness.

Public health relevance
PROJECT NARRATIVE Using video, survey, and direct assessment data from the NICHD-funded Baby Books 2 study, this project explores mothers’ and fathers’ verbal input around math (i.e., math talk), in English and Spanish, when their first-born child is 9, 18, 24, and 30 month age. We then assess if and how early math talk, in total, by each parent, and across domains (counting, spatial relations), is related to math skills at 38-46 months of age.